Elucidating the role of hepatic ketogenesis in pancreatic cancer cachexia and recovery

PROJECT SUMMARY/ABSTRACT
80% of patients with Pancreatic Ductal Adenocarcinoma (PDAC) develop cachexia, which results in dispropor-
tionate skeletal muscle mass loss, relative to caloric deficits. Cachexia causes functional impairment and ineli-
gibility for anti-tumor therapeutic interventions, leading to drastically lower patient quality of life and increased
mortality. Supplemental nutrition is not sufficient to prevent tissue loss, and there is an abject lack of targeted
anti-cachectic therapeutics. This is largely due to an incomplete understanding of how effectors, such as inter-
leukin 6 (IL-6), drive cachexia, and mechanistic studies that poorly reflect the clinical scenarios of PDAC survi-
vorship. Improving the quality of life and survivorship of patients with PDAC requires that we address a funda-
mental knowledge gap in the mechanisms of cachexia persistence after cancer recovery. Our recent work shows
that systemic inflammation in PDAC prevents the liver from adapting to ketogenic metabolism during nutritional
scarcity, which leads to muscle loss. Loss of hepatic signal transducer and activator of transcription 3 (STAT3)
is sufficient to restore ketogenic potential and prevent muscle loss in PDAC mice. This work is the first to show
that improving hepatic fatty acid oxidation prevents cachexia progression. To improve the translation of these
findings we must address two unmet needs: 1) the mechanism of STAT3-driven down regulation of lipid oxidation
and 2) studies that address cachexia recovery in cancer survivors. Based on our prior work, we hypothesize that
STAT3 signaling acts on the liver to induce metabolic changes that persist after cancer recovery, at the detriment
of the muscle. This project is innovative because it uses advanced epigenetic techniques combined with a novel
mouse model of PDAC survivorship to clearly define the epigenetic reprogramming events that persist after
tumor clearance and increase vulnerability of muscle to nutritional stress. The significance of this project lies in
pre-clinical testing of metabolic interventions to protect muscle during PDAC recovery, defining a previously
undescribed action of STAT3 in hepatic metabolism control, and linking long-term metabolic dysfunction to epi-
genetic reprogramming during PDAC cachexia. The long-term goal of our research is to improve the quality of
life, from diagnosis through survivorship, of patients with cancer cachexia through a mechanistic understanding
of inter-organ metabolic events.

Public health relevance
PROJECT NARRATIVE Despite advances in detection and treatment of pancreatic cancer, there remains no clinically efficacious treat- ment for cachexia—the severe wasting syndrome that accompanies 80% of pancreatic cancer cases. The work in this proposal combines advanced epigenetic techniques with a novel mouse model for pancreatic cancer survivorship to study the molecular underpinnings of sustained metabolic deficits after cancer recovery. Expand- ing our understanding of the persistence of metabolic symptoms after cancer recovery will provide vast benefit to improving the quality of life for patients experiencing and surviving from pancreatic cancer.